2/1 Arrest Respiratory Failure due to Pneumonia (ARREST PNEUMONIA)

Core Summary/Abstract
The Arrest Respiratory Failure due to Pneumonia (ARREST PNEUMONIA) Data Coordinating
Center (DCC) will fulfill an essential need to ensure that the ARREST Pneumonia trial will
achieve its mission to establish the efficacy of ancillary therapy directly targeting the lung injury
that occurs with pneumonia. Critical to carrying out the trial’s success is DCC oversight of the
implementation of the study design and randomization scheme, performing the interim and final
data analysis, regular data and safety monitoring reports, the timely dissemination of findings,
and data and resource sharing. To meet its goals, the DCC will employ open-­source secure
web-­based tools such as REDCap for housing data across the 10 sites and allowing web-­based
randomization;; appropriate statistical techniques, including methods for the analysis of time-­to-­
event data in the presence of competing risks;; and expertise in clinical trial design and data
safety monitoring. The DCC includes a stellar team with extensive experience in innovative
clinical trial designs, statistical modeling, managing large and complex data sets, and monitoring
data quality. Importantly, the operation of the DCC will rely heavily on the philosophy that DCC
members should be fully integrated into the trial’s research team as well as in the infrastructural
support in order to optimally meet the trials data-­related and coordination needs. To that end,
the DCC is composed of five support teams corresponding to key support functions of a
biostatistics and data coordinating center. The DCC’s structure will ensure the success of the
scientific goals for ARREST Pneumonia by designing and monitoring the trial, developing a
database in REDCap, providing specific expertise on safety monitoring and quality control,
implementing analyses, and providing principal interpretation for dissemination.

Public health relevance
Core Narrative/Scientific Relevance Critical to achieving the scientific mission of the Arrest Respiratory Failure due to Pneumonia (ARREST Pneumonia) trial is the oversight of the implementation of the study design, regular data and safety monitoring reports, and the timely dissemination of findings. The ARREST Pneumonia DCC will meet these essential needs by employing open- source secure web- based tools such as REDCap for housing data across the 10 sites and allowing web- based randomization;; appropriate statistical techniques, including methods for the analysis of time- to- event data in the presence of competing risks;; and expertise in clinical trial design and data safety monitoring. The ARREST Pneumonia DCC will ensure the success of the scientific goals for ARREST, which are strongly aligned with the goals of the NHLBI, by designing and monitoring the trial, developing a database in REDCap, providing specific expertise on safety monitoring and quality control, implementing analyses, and providing principal interpretation for dissemination.